Transitions from Impaired Respiratory Health to Lung Disease

PROJECT SUMMARY / ABSTRACT
The greatest driver of respiratory-related morbidity in people with and without chronic lung disease is medically
attended respiratory illnesses (MARI) such as respiratory viral infections, pneumonia, and acute exacerbations
of chronic lower respiratory disease. While several studies have identified radiologic and molecular factors
associated with respiratory exacerbations in older smokers with established lung disease, few studies have
identified factors predictive of respiratory morbidity earlier in life in the general population when prevention
strategies have their greatest impact. The Coronary Artery Risk Development in Young Adults (CARDIA) study
(community-based prospective study, age 18-30 at inception, 40 years follow-up and recent contact in 79.3%
of the surviving cohort) represents an ideal cohort to ascertain early factors that predict future respiratory
events in a general population. In prior funding periods, our group has defined impaired respiratory health as a
precursor to chronic lung disease. We identified radiologic features of subclinical lung injury (quantitative
interstitial abnormality on CT scan) and lifecourse lung function trajectories that precede the development of
COPD/emphysema and pulmonary fibrosis. We discovered circulating proteins that reflect activation of
pathways related to innate immunity, fibrosis, and metabolic dysfunction that are associated with impaired
respiratory health manifesting as accelerated loss of lung function and early lung injury on CT scan. We
hypothesize that these radiologic and molecular biomarkers of impaired respiratory health measured in middle
age are associated with future MARI and inform the mechanistic underpinnings of susceptibility to respiratory
morbidity. This renewal of the CARDIA Lung Study proposes to integrate our framework of impaired respiratory
health to identify molecular, radiologic, and genetic features relevant to future respiratory morbidity. We will
quantify proteins that comprised our predictive panel testing against prospectively adjudicated MARI in
CARDIA, a critical step for clinical translation to the general population. We will next integrate existing CT-scan
based parenchymal features with novel pulmonary vascular and airway measurements to create a
comprehensive atlas of the human lung in middle age. We will identify combinations of features within the CT
atlas that influence the risk of MARI in CARDIA. Finally, we will evaluate whether and where proteins in our
proteomic signature of impaired respiratory health are expressed in diseased lung tissue and thereby have the
potential to be causal therapeutic targets for the prevention of chronic lung disease.

Public health relevance
PROJECT NARRATIVE Public health relevance: Medically-attended respiratory illnesses create major burdens to the population. Identifying markers of impaired respiratory health that predict these respiratory events and are rooted in lung pathobiology can ultimately lead the interception and prevention of future respiratory morbidity.